Targeting ASK1 as a novel therapy to treat biliary atresia

Abstract Text
The objective of this STTR proposal is to conduct efficacy and mechanistic studies of SRT-015 for the treatment
of neonatal biliary atresia (BA) and to support an IND. Biliary atresia (BA) is the most common cause of neonatal
cholestasis in early infancy and results from a fibro-inflammatory obstruction of extrahepatic bile ducts. Despite
nearly uniform progression to end-stage cirrhosis, the variable response to surgical/medical treatment and
rate of progression of disease suggest the existence of unrecognized biological processes that not only drive the
disease phenotype but also provide untapped opportunities to develop newer therapeutic approaches. SRT-015
is a novel apoptosis signal-regulating kinase (ASK1) inhibitor with demonstrated efficacy in diverse models of
liver disease. Here, we mined the murine extrahepatic bile duct and human liver transcriptome and built networks
of ASK1 (MAP3K5) linked genes. The analytics identified proinflammatory gene signatures intricately linked to
activation of ASK1 as well as components of the p38-MAPK axis as a potential therapeutic target to suppress
inflammation and fibrosis. Using immunohistochemistry and liver specimens from human and experimental BA,
we uncovered localization of ASK1 and p38-MAPK signals to proliferating cholangiocytes within areas of ductular
reaction and immune cell infiltrations. These data form the foundation for the preclinical studies proposed in two
inter-related aims. In Aim 1, we will establish the dosing schedule and optimal therapeutic dose of SRT-015 in
preclinical models of bile duct cholangiopathy and liver fibrosis to achieve remission from cholestasis and
improved survival with native liver. We will use the rhesus rotavirus (RRV)-induced neonatal mouse models of
extrahepatic bile duct disease and liver fibrosis that recapitulate BA patient phenotypes. The minimum efficacious
QD or QOD dose to attenuate jaundice, cholestasis markers, improve survival with native liver, and reduce liver
fibrosis will be identified using three dose levels of SRT-015. Safety will be determined by observing for adverse
effects. In Aim 2, we will perform detailed evaluation of the pharmacotherapeutic efficacy and mechanisms of
SRT-015 to block injury and obstruction of the extrahepatic bile ducts and liver fibrosis at early and established
disease stages. This approach aims to examine the potential benefits of SRT-015 in early stages of bile duct
injury and inflammation, as well as established biliary disease and liver fibrosis. We will evaluate biomarkers,
histology, liver immune cell phenotyping, and levels of gene expressions to interrogate the mechanisms. Our
work will fully expand the efficacy data for SRT-015 in correcting in vivo bile duct and liver pathologies, and
attenuation of liver fibrosis, providing essential preclinical data for future clinical trials in infants and children with
biliary atresia. Once approved, SRT-015 is anticipated to extend the time to or ideally prevent the need for liver
transplantation and significantly improve the lives of patients with biliary atresia.

Public health relevance
Public Health Relevance Statement Biliary atresia (BA) is a rare and progressive severe liver disease limited to early infancy. BA is a common indicator for pediatric liver transplantation and in the US alone, more than 600-800 live births are diagnosed with BA every year. Infants with BA face severe health crisis; however, no pharmacological therapies are available. Seal Rock Therapeutics proposes to address this unmet need with SRT-015, a liver-selective, potent inhibitor of ASK1 kinase that demonstrates in vivo and in vitro anti-inflammatory, anti-fibrotic and anti-apoptotic activity. SRT-015 is effective in acute and chronic liver mouse models with a safety profile and no dose-limiting toxicities in a Phase 1 clinical trial. Demonstrating preclinical efficacy in disease-relevant mouse and human models will be critical to advance SRT-015 to clinical trials and improve the lives of infants with BA.